PROJECT 2: Imaging sex differences in stress-related cellular function in alcohol use disorder

PROJECT 2 ABSTRACT
It is increasingly clear that women are more vulnerable than men to some of the negative effects of chronic
alcohol consumption, including stress and immune system dysfunction. We have preliminary data indicating
significantly greater neuroimmune impairment in females than males with alcohol use disorder (AUD), which is
in line with the idea of greater vulnerability to the neurotoxic effects of alcohol in women vs. men. This is
important since the rates of problem drinking in women are rapidly increasing, and the currently available
treatments are only minimally effective. There is clear evidence that women and men drink for different
reasons. Women tend to drink to regulate stress and negative affect, whereas men report drinking for alcohol-
related positive reinforcement and stimulatory effects. This motivates a critical need to explore sex differences
in stress-related neurochemical mechanisms underlying AUD to inform treatment approaches that are effective
for women. The current project will focus on identifying sex differences in phosphodiesterase 4B (PDE4B), a
regulator of intracellular signaling in the immune pathway, that has a demonstrated role in AUD and is a
promising medication target. PDEs are enzymes that regulate the concentration of cyclic adenosine
monophosphate (cAMP), a second messenger functioning as an intracellular signal. cAMP plays a key role in
neuroimmune pathways including in the induction of anti-inflammatory responses and the resolution of
inflammation, and cAMP-dependent pathways are critical in medications treating immune disease. PDE4B is
the main PDE subtype involved in neuroimmune signaling and mood regulation and is located in microglia that
are in brain regions regulating reward and affect. However, little is known about the role of PDE4B in people
with AUD. Using state-of-the-art positron emission tomography (PET) brain imaging techniques with the new
PDE4B-specific radiotracer [18F]PF-06445974 ([18F]PF974), we can measure PDE4B in the living human brain.
In the current project, we propose to examine, for the first time, sex differences in PDE4B in the brains of
females and males with AUD compared to control groups with [18F]PF974 and PET (Aim 1). We will examine
relationships between PDE4B levels and clinical outcomes (Aim 2) and determine brain penetration of a
PDE4B inhibitor (Aim 3) that has potential to treat AUD. Overall, we hypothesize that females with AUD will
have greater deficits in PDE4B than males with AUD that are associated with greater stress-reactivity, mood
impairment, and cognitive dysfunction. These findings could significantly advance the alcohol field by indicating
PDE4B as a treatment target with potentially greater benefit to women with AUD.

Public health relevance
PROJECT 2 NARRATIVE Rates of alcohol use disorder in women continue to increase and, alarmingly, rates of alcohol-related deaths have recently increased at a greater rate in women than in men. We know that increased sensitivity of the stress system and deficits in the reward system drive compulsive drinking, particularly for women. We will investigate sex differences in stress-related brain mechanisms underlying alcohol use disorder, to better inform treatment approaches that are effective for women.